IGF::OT::IGF: NAS/IOM forum strategies that promote mental, emotional and behavorial health of children and adolescents.

Enhancing Implementation, Sustainability and Ongoing Improvement of Evidence-Based Interventions for the Prevention of Mental, Emotional, and Behavioral Disorders